STRESS MODELS FOR HIGH RISK POPULATION

The applicant's broad objective is to develop expertise in basic epidemiologic research that can be used to develop preventively oriented intervention programs. To this end, three basic aims are proposed: first, to continue a line of research already begun by the applicant that develops disaggregated models of the stress process with nonexperimental epidemiologic survey data; second, to become more broadly involved in an ongoing program of preventively oriented research with unemployed workers in Eastern Michigan; third, to develop a new program of basic research in a population of families who are caring for psychiatric patients in the community. The research experiences encompassed by the activities in these three aims will expose the applicant to a full range of professional growth opportunities relevant to his overarching career development objective.